Cancer Genomics Facility

Abstract: Cancer Genomics Facility (CGF)
Cancer genomic and transcriptomic studies have grown increasingly more complex with a wide variety of
techniques now available, including whole exome, genome and transcriptome; methylation; single cell
sequencing; etc. For both new and established investigators this landscape can be difficult to navigate. The
Cancer Genomics Facility (CGF) is a resource that is intimately tied to the Cancer Bioinformatics Services
(CBS) and Biostatistics Facility (BF), providing a seamless concierge service for HCC investigators navigating
this complex landscape. The CGF offers next generation sequencing support for clinical, translational and
discovery-based cancer biology with a scope of other services that span from customized arrays to single cell
genomics. Implementation of high throughput sequencing approaches continues to require expensive
instrumentation; capabilities that lie beyond the scope of most individual laboratories. The CGF allows for
these investigators to gain access to state-of-the-art next-generation sequencing at reduced rates. These
services paired with informatics and statistical support by CBS and BF allows for investigators to explore all
aspects of cancer genomics.